JUNTOS (TOGETHER): Development of a family-based Latino youth use preventive intervention

Project Summary/Abstract: This K01 research and training award would advance my long-term goal of devel-oping and evaluating culturally and developmentally appropriate Latino youth alcohol use preventive interven-tions. Compared to Blacks and Whites, Latinos in middle adolescence (ages 14–16) are disproportionately at
risk for alcohol use. Although by late adolescence (ages 18-20) rates of underage drinking for Latinos is similar
to those for Whites, alcohol use risks (e.g., drunk driving, unplanned/unprotected sex) are more severe for Lati-nos. Normative adolescent stressors partly explain why many youth initiate alcohol use. Yet, Latino youth and
families face additional stressors related to prejudice, discrimination, and racism, leaving Latino youth vulnera-ble to higher alcohol use/related risks. Many studies have documented the impact of prejudice, discrimination,
and racism on Latino youth alcohol use. Yet, we know almost nothing of how to prepare Latino youth and fami-lies to live in a world in which prejudice, discrimination, and racism are part of their daily life. Evidence-based
preventive interventions for Latinos have not targeted coping skills for prejudice, discrimination, and racism.
Yet, it might be precisely these skills that youth and parents are lacking that are driving Latino youth alcohol
use disparities. Although, evidence-based preventive interventions for Latinos exist, Latino youth continue to
be at disproportionately higher alcohol use risk, suggesting that more preventive intervention development
work is needed. The overarching goal of my K01 research plan is to develop and pilot test a family-based
youth alcohol use preventive intervention that will equip youth and parents with coping skills to manage preju-dice, discrimination, and racism. My training plan will provide me with the skills necessary to become an inde-pendent youth alcohol use prevention scientist. I will acquire training in qualitative/mixed methods used in
inter-vention development; the development and implementation of preventive interventions; and the evaluation of
preventive intervention outcome data. My training plan is directly linked with my three research aims. For Aim
1, I will use qualitative methods to inform the development of intervention sessions that target coping with prej-udice, discrimination, and racism. For Aim 2, I will create intervention sessions that target coping with preju-dice, discrimination, and racism. I will draw from strategies used in existing interventions and from Aim 1 focus
group data. I will seek feedback from youth and families before finalizing the curriculum. For Aim 3, I will pilot
test the intervention among Latino families; assess intervention feasibility and acceptability; and determine pre-liminary effect size estimates for the intervention’s promise to improve coping skills, family functioning, parent-ing behaviors, and youth alcohol outcomes. The proposed research will contribute to the first family-based
La-tino youth alcohol use preventive intervention targeting coping skills for prejudice, discrimination, and racism. It
will provide me with the training, experience, and pilot data necessary for a fully powered randomized trial
(R01), facilitating the leap to independent investigator and Latino youth alcohol use prevention scientist.

Public health relevance
Project Narrative Underage drinking is a serious public health problem because alcohol is the most widely used substance of abuse among adolescents and it has been associated with a range of health related risks such as drunk driving, unprotected sexual activity, school dropout, injuries, homicide, suicide, and lost productivity. Latino middle adolescents (age 14-16), in particular, experience health disparities related to alcohol use/related risks that represent major costs to society. Thus, preventing alcohol use/related risks among Latino youth via culturally and developmentally appropriate family-based preventive interventions is critically important and makes the proposed research relevant to NIAAA's strategic plan to develop and evaluate developmentally and culturally appropriate, preventive interventions for specified minority populations.